Detection of Liver Fibrosis Using IVIM Diffusion and DCE MRI in HCV

DESCRIPTION (provided by applicant): There is an expected increased incidence of chronic hepatitis C virus infection (HCV) in the Unites States within the next years, with subsequent increased risks of liver damage, including fibrosis and cirrhosis, which may eventually lead to hepatocellular carcinoma and end-stage liver disease requiring liver transplantation. This disease is/will be the source of enormous health care costs and morbidity/mortality. Most hepatologists still rely on liver biopsy findings in patients newly diagnosed with HCV, which enables the assessment of liver damage (fibrosis and inflammation). Liver biopsy has limitations, including cost, invasiveness, poor patient acceptance, limited sampling, inter-observer variability and is difficult to repeat. Non invasive tests to capture the extent of liver damage at a larger scale are urgently needed. These will gain more acceptance among patients and hepatologists. In this proposal, we would like to test and validate non invasive magnetic resonance imaging (MRI) methods based on advanced diffusion (intravoxel incoherent motion diffusion MRI: IVIM DW-MRI) and dynamic contrast-enhanced MRI (DCE-MRI) for the detection of fibrosis and cirrhosis in HCV patients. Based on our recent preliminary data, we believe that the combination of IVIM DW- and DCE-MRI has potential for detection of fibrosis and cirrhosis with excellent accuracy, while enabling coverage of the whole liver. In order to improve the diagnostic performance of MRI, we would like to build and validate a predictive model based on advanced functional MRI metrics (diffusion and perfusion). If validated, this novel non invasive algorithm will not only decreases the number of liver biopsies, but also enable earlier diagnosis of liver fibrosis when antiviral treatment is more effective, and enable a comprehensive evaluation of the liver (to assess for cirrhosis, portal hypertension and hepatocellular cancer). This could significantly reduce the cost of care, could become a useful tool for testing new antifibrogenic and antiviral drugs in HCV, and could be used to follow patients for detection of progression to cirrhosis. This will be a highly significant progress in liver diseases given the increased burden of HCV in this country, and would benefit a large number of Americans over the next decade.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with hepatitis C virus infection (HCV) are at high risk of developing liver scarring (fibrosis), with ultimate risks of cirrhosis and liver cancer that may require liver transplant. We would like to develop non invasive advanced MRI techniques (diffusion and dynamic contrast-enhanced MRI) to assess the degree of liver damage in HCV. These techniques combined could reach high diagnostic performance for detection of liver fibrosis; and could decrease the number of necessary liver biopsies, which have risks and sample only a small portion of the liver. Project Narrative Patients with hepatitis C virus infection (HCV) are at high risk of developing liver scarring (fibrosis), with ultimate risks of cirrhosis and liver cancer that may require liver transplant. We would like to develop non invasive advanced MRI techniques (diffusion and dynamic contrast-enhanced MRI) to assess the degree of liver damage in HCV. These techniques combined could reach high diagnostic performance for detection of liver fibrosis; and could decrease the number of necessary liver biopsies, which have risks and sample only a small portion of the liver. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The broad, long¿term objective of this proposal is to develop non invasive tools for staging liver fibrosis in chronic hepatitis C virus infection (HCV) based on intravoxel incoherent motion (IVIM) diffusion-weighted (DW) MRI and dynamic contrast-enhanced (DCE) MRI methods. The clinical validation of noninvasive MR biomarkers of fibrosis has essential diagnostic and prognostic value. Non invasive MR markers could facilitate earlier diagnosis, improve monitoring of disease progression in HCV, limit the need for liver biopsies and enable the assessment of novel antifibrotic and antiviral therapies. Morbidity and mortality associated with HCV is expected to increase dramatically in the next decade in the U.S. [25-27]. HCV patients are at high risk of developing liver fibrosis and cirrhosis. Antiviral therapy can slow or even reverse progression of disease [28]. Accurate staging of liver fibrosis ─commonly determined from liver biopsy─ is critical as it determines the indication of antiviral treatment, and prognosis [cirrhotic patients are at higher risk of end stage liver disease, portal hypertension and hepatocellular carcinoma (HCC), and are less likely to respond to antiviral therapy] [19-21]. However, liver biopsy is invasive, expensive, limited by sample size and difficult to repeat. Thus, non invasive tools to assess the degree of fibrosis of the whole liver are urgently needed. Our exciting new data show that changes observed in liver fibrosis can be non invasively detected using DWMRI with/without the use of the IVIM model [3, 6, 11] and DCE-MRI [4]. Our results underscore the potential value of these two techniques alone and in combination to stage liver fibrosis non invasively. Specific Aim 1: To determine the diagnostic performance of diffusion and perfusion metrics derived from IVIM DW-MRI for staging liver fibrosis in HCV. Hypothesis: In liver fibrosis, there is decreased hepatic perfusion fraction (PF) and pseudo-diffusion coefficient (D*) secondary to liver perfusion changes, decreased D (true diffusion coefficient) secondary to increased collagen deposition, and decreased apparent diffusion coefficient (ADC) secondary to both decreased perfusion and increased collagen deposition. We will prospectively determine in a cohort of 90 HCV patients (training set) whether IVIM parameters are valid markers of liver fibrosis, using histopathology from liver biopsy or explant as the reference. Specific Aim 2: To determine the diagnostic performance of perfusion metrics derived from DCE-MRI and a dual input single compartmental model for staging liver fibrosis in HCV. Hypothesis: In liver fibrosis, there is an increase in hepatic time to peak (TTP), arterial flow (Fa), arterial fraction (ART), mean transit time (MTT) and distribution volume (DV) and a decrease in hepatic portal venous flow (Fp) and upslope. We will prospectively determine in a cohort of 90 HCV patients (training set) whether DCE-MRI parameters are valid markers of liver fibrosis, using histopathology from liver biopsy or explant as the reference. Specific Aim 3: 1) To build a predictive model for detection of liver fibrosis based on combined IVIM DW- and DCE-MRI parameters using criteria identified in specific aims 1 and 2 in the training population, and 2) Perform an independent prospective study to test the accuracy of the model in a different cohort of patients (validation population). Hypothesis: A predictive model combining IVIM- and DCE-MRI parameters provides high accuracy for non invasive detection of liver fibrosis. We will build a predictive model for detection of liver fibrosis and cirrhosis combining IVIM and DCEMRI parameters, and we will validate it prospectively in 55 different HCV patients (validation population).